Development of novel therapeutics for obesity and type 2 diabetes

PROJECT SUMMARY / ABSTRACT
Obesity and type 2 diabetes affect millions of patients worldwide and have enormous clinical impact but are not
fully addressed by existing pharmacotherapies. Two of the most important unmet medical needs are for
pharmacologic agents that promote weight loss without muscle loss, and for pharmacologic agents that protect
against dysfunction of pancreatic beta cells. A major goal of our company, Emmyon, Inc., is to discover and
develop new pharmacologic agents for obesity and type 2 diabetes. Emmyon is led by physicians and
scientists with clinical and scientific expertise in obesity and type 2 diabetes, and by an exceptional medicinal
chemist who has been lead inventor of 8 FDA-approved drugs to date. In Phase I-equivalent studies, Emmyon
discovered and patented a confidential and proprietary small molecule (EMMY1-25) that promotes weight loss
without muscle loss and that protects against dysfunction of pancreatic beta cells in well-established in vivo
mouse models of obesity and type 2 diabetes. EMMY1-25 is orally administered and possesses excellent oral
bioavailability, pharmacokinetics, and tolerability in rodent models, strong efficacy towards obesity and type 2
diabetes, and pharmacologic effects (promotion of weight loss without muscle loss, and protection against
dysfunction of pancreatic beta cells) that could fill important unmet needs in clinical management of obesity
and type 2 diabetes. In this Phase II SBIR proposal, we seek to continue this exciting work by advancing the
development of EMMY1-25 and related molecules as pharmaceuticals for obesity and type 2 diabetes.
Specifically, we will further investigate EMMY1-25's safety, efficacy, dose response, and mechanisms of action
in four distinct and complementary mouse models of obesity and type 2 diabetes, and in cultured pancreatic
islets from humans with type 2 diabetes. In parallel to our detailed studies of EMMY1-25, we will also design,
synthesize, and characterize novel compounds that are structurally related to EMMY1-25, seeking to discover
additional compounds with pharmacologic properties that are similar to or perhaps even better than those of
EMMY1-25 in preclinical models of obesity and type 2 diabetes. Collectively, these studies will rigorously
advance the scientific understanding and commercial development of a highly innovative and promising new
class of pharmaceutical agents. In SBIR Phase III, the most promising compound from this project will be
carried forward into an IND application and clinical studies geared towards FDA approval for the treatment of
obesity and type 2 diabetes. Through this work, we hope to ultimately discover and develop a pharmacologic
agent that could significantly improve clinical outcomes for millions of patients who suffer from obesity and type
2 diabetes.

Public health relevance
PROJECT NARRATIVE Obesity and type 2 diabetes affect millions of patients worldwide and have enormous clinical impact but are not fully addressed by existing pharmacotherapies. Two of the most important unmet medical needs are for pharmacologic agents that promote weight loss without muscle loss, and for pharmacologic agents that protect against dysfunction of insulin-secreting pancreatic beta cells. To help address this issue, we propose a Phase II SBIR study to investigate and develop a new and promising class of potential medications for obesity and type 2 diabetes that promote weight loss without muscle loss and that protect against dysfunction of pancreatic beta cells.